Cytek Aurora CS

SUMMARY / ABSTRACT
The Flow Cytometry Core Facility (FCCF) in the School of Medicine at the University of Virginia (UVA) seeks
funds for the purchase of a Cytek Aurora CS Full Spectral Cell Sorter. UVA was an early adopter of mass
cytometry and spectral flow cytometry, and the FCCF currently houses two Cytek Aurora Full Spectral
Cytometers that serve a broad user base spanning diverse fields of study. These technologies have the major
advantage over conventional flow cytometry of resolving much higher numbers of fluorescent parameters. This
feature enables paralleled phenotyping of many more cell types, and elucidation of molecular signatures to a
much higher degree of complexity. A group of Major and Minor users currently utilize fluorescent panels to detect
up to 41 parameters in human and mouse models to analyze complex cellular systems. The Cytek Aurora CS
Full Spectral Cell Sorter will seamlessly integrate with available technologies in the Core and accomplish the
following key objectives: (1) allow the transition of already optimized high-dimensional fluorescent panels directly
from existing Aurora Spectral Cytometers to the Aurora CS Cell Sorter to enhance multiple ongoing research
programs; (2) enable high purity cell sorting on complex cell subsets that require up to 41 fluorescent markers,
to isolate cells for functional assays and other single-cell downstream applications; (3) provide parallel sorting
on up to 6 different populations; and (4) provide the ability to sort and recover high-dimensional analytical data,
thereby maximizing data generated on valuable human specimens that may contain low numbers of cells.
The FCCF evaluated three cell sorters with the ability to provide high-dimensional sorting, and chose to demo
two of them based on user needs. The Cytek Aurora CS Full Spectral Cell Sorter was found to be the best suited
to achieve our objectives and serve our investigators’ needs for current and future investigations.

Public health relevance
PROJECT NARRATIVE The isolation of cell populations for conducting in-depth characterization of immune cells, cancer cells, and organ-specific cells, helps researchers to understand how cells function in both health and disease. This application requests a specialized instrument that is capable of identifying and isolating individual cells based on their complex molecular features using many more markers than conventional instruments. Implementation of this cell sorter will be critical to investigators’ needs at the University of Virginia for current and future investigations.